Sex and Gender Curricular Assessment and Revision (SG-CAR)

Project Summary/Abstract
The proposed faculty development project at Prisma Health-Upstate and The University of
South Carolina School of Medicine Greenville (SOMG), Sex and Gender Curricular Assessment
and Revision (SG-CAR), will create innovative and sustainable faculty development materials
for use at SOMG and by other health professions educators across the globe, and it will provide
training to faculty and medical students at SOMG on how to incorporate sex and gender into
medical education. The overall goal of this project is to reduce existing faculty barriers to
integrating sex and gender content into medical curricula by providing faculty with the
knowledge, skills, tools, and practical experience in this work. The project will be led by national
and foundational experts at SOMG in sex and gender health, lifestyle medicine, and medical
education curriculum development. Each Co-PI has a long history of developing educational
resources for faculty development which demonstrates their ability to successfully develop such
projects. Specific Aim 1 of this project will include creating an introductory curriculum that will be
developed for current SOMG faculty emphasizing the importance of sex and gender aspects of
health and disease. Faculty will be provided with a sex and gender curricular assessment
instrument and a curricular revision toolkit created by Dr. Alyson McGregor, Associate Dean at
SOMG, which she piloted successfully at the Warren Alpert Medical School of Brown University
in 2021-22. These materials will be refined and validated at SOMG and distributed publicly
through the National Institutes of Health as part of this project. In Specific Aim 2, faculty who
completed the training in Specific Aim 1 will lead teams of students to assess the Lifestyle
Medical Education (LMEd) curriculum for sex and gender content using the assessment
instrument. LMEd is presented by SOMG in strategic partnership with the American College of
Lifestyle Medicine. It is freely available to health professions faculty and is currently accessed
by 28 U.S. medical schools and other schools within 57 countries. In Specific Aim 3, faculty will
lead teams of students using the toolkit to revise the LMEd curricular materials to include sex
and gender content. This will enable these students to publish their work and establish
themselves as future leaders in sex and gender health. The revised LMEd curriculum will be
freely available to educators worldwide through the existing LMEd website. We anticipate a
broad adoption of these faculty development materials. We expect that it will translate to
improved sex and gender specific evidence-based clinical care for women, thus reducing
mortality and morbidity that currently exists among women.

Public health relevance
Project Narrative The proposed Faculty Development project creates and validates an introductory sex and gender faculty development curriculum which provides faculty with the knowledge and tools to assess and revise their curricular materials, and it creates enduring sex and gender faculty development materials for use by others. This will be implemented with a select group of faculty members at the University of South Carolina School of Medicine Greenville (SOMG) to educate faculty and enable them to work with medical students to assess the renowned Lifestyle Medical Education (LMEd) curriculum at SOMG for sex and gender content, and to integrate sex and gender content into the LMEd curriculum for future faculty audiences. This project will: develop a cadre of leaders in sex and gender health among SOMG faculty and students, result in publications in sex and gender health topics and sex and gender curricular tools by SOMG faculty and students, and create enduring, widely-disseminated faculty development materials that will enable faculty to adopt sex and gender content across U.S. medical schools, thus improving population health by facilitating the provision of clinical care for women which is sex and gender specific.